Neurobiology Training Program

Abstract
This application seeks support for early-stage training of doctoral students in the neurosciences at Duke
University. The goal of this comprehensive, broad-based, interdisciplinary Neurobiology Training Program
(NBTP) is to train top-level neurobiologists for research-oriented positions in academia, industry, and related
arenas. The application seeks funding for 8 predoctoral trainees each year, 4 in their first year and 4 in their
second year. Drs. Richard Mooney, Jörg Grandl, and Lindsey Glickfeld serve as the Program Director, Director
of Graduate Studies, and Assisting Student Advisor, respectively, and direct the program in concert.
Preceptors are drawn from 16 departments across the School of Medicine, the School of Engineering and the
College of Arts and Sciences and represent a broad diversity of fields including molecular, cellular, circuits,
systems, behavioral, computational, translational and cognitive neuroscience. Preceptors include scientists
with long and distinguished records of achievement as well as recently recruited, talented young faculty. A
large pool of >250 applicants per year permits recruitment of a talented, diverse class of ~10 new trainees
each fall. Close to half of the matriculants will be supported in their first year by the Duke Graduate School,
which enables the program to pull from international as well as domestic pools.
Trainees undergo extensive training including demanding coursework addressing the depth and breadth of
fundamental and translational neuroscience, including experimental design, technical implementation, data
analysis, and interpretation. Required course work emphasizes molecular and cellular neuroscience; circuits
and systems neuroscience; the neurobiology of disease; quantitative, statistical and computational
neuroscience methods; scientific writing and grant writing; written and oral presentation; teaching and career
development. Individual thesis committees, the Director of Graduate Studies and Assisting Student Advisor,
and the Program Steering Committee carefully monitor trainees progress throughout the entire period of
graduate training.
Students in our program are expected to obtain their doctoral degree within 5-6 years and to publish original
research articles stemming from their doctoral studies. Upon completion of postdoctoral fellowships and clinical
training (where applicable), we expect that our graduates will secure tenure-track faculty positions in research
institutions, obtain neuroscience-related jobs in industry, use their neuroscience training to practice medicine,
and teach and train the next generation of neuroscientists at the graduate and undergraduate levels.
The NBTP makes extensive efforts to recruit and retain students from underrepresented groups. The goal of
the program is to train a new and diverse generation of scientists equipped with the knowledge, imagination
and insight needed to cross disciplinary boundaries in search of a new and deeper understanding of the basis
of nervous system function in health and disease.

Public health relevance
Project Narrative The mission of the Duke Neurobiology Training Program (NBTP) is to train the next generation of leading scientists who will discover how the nervous system normally functions to enable a myriad of complex processes, including learning, memory, movement, behavior, sensation, and perception, and how to restore normal function of the nervous system in the face of trauma and disease. The major objective of the NBTP is to endow young scientists with the intellectual breadth, technical flexibility and scientific rigor to grow and adapt to the demands of neuroscience research now and over the next several decades, enabling them to successfully navigate the variety of scientific career paths that will span the neuroscience research enterprise of the future.